Research Project-Pain: Culturally Adapted Cognitive Behavioral Based Physical Therapy for Latinos with Chronic Spine Pain

RESEARCH PROJECT-PAIN – Project Summary
Spine pain is among the most common musculoskeletal complaints in the workplace, with a high prevalence
among racial/ethnic minorities and an estimated annual cost of up to $100 billion in reduced productivity and
lost wages. Spine pain also reduces quality of life for affected individuals and their families. Hispanics/Latinos
report more frequent and severe episodes of work-related musculoskeletal pain than Caucasians, yet most
existing interventions for chronic spine pain have been developed and tested in predominantly Caucasian
populations. Consistent with the Department of Human Health National Pain Strategy, our long-term goal is to
develop accessible, effective, and culturally informed management strategies for individuals with chronic spine
pain to reduce disparities in pain prevention and management. The current application proposes a multi-site
randomized controlled clinical trial (RCT) to assess the feasibility, acceptability, and efficacy of a 6-week
cognitive-behavioral-based physical therapy (CBPT) tele-rehabilitation intervention for Hispanics/Latinos with
chronic spine pain from medically underserved urban and rural communities. In Phase I, we will conduct
formative research with focus groups to adapt a CBPT intervention that has proven effective for optimizing
rehabilitation outcomes after lumbar spine surgery to the conservative management of chronic spine pain in
Hispanics/Latinos. In Phase II, we will conduct a multi-site RCT to assess the efficacy of the adapted CBPT
tele-rehabilitation program compared to usual care in Hispanics/Latinos from urban and rural communities. We
also will use ecological momentary assessment and wearable sensor technologies to explore psychological,
behavioral, and environmental predictors and mediators of treatment response. Together, these aims will
inform the design of future studies to determine best practices for dissemination and implementation of the
CBPT tele-rehabilitation intervention among Hispanics/Latinos with chronic spine pain with the ultimate goal of
reducing health disparities in pain management.